The role of Nerve-fibroblast communication in EDS pain

Classic Ehlers Danlos Syndrome (cEDS) is characterized by skin hyperextensibility and fragility, wound
healing problems, and joint hypermobility. cEDS is caused by genetic defects in genes that encode type V
collagen (COL5A1 and COL5A2). Chronic widespread pain is one of the most common and intractable, yet
barely studied, complaints in all EDS patients, and cEDS patients are in great need of new non-opioid pain
therapies. Research into the characteristics and mechanisms of pain in EDS is exceedingly limited. A unique
collaboration between the Chicago Center on Musculoskeletal Pain (C-COMP) and the Center for Medical
Genetics at Ghent University (Belgium) has uncovered critical, novel observations in cEDS patients and in
Col5a1 haploinsufficient (Col5a1+/-) mice, a validated model of cEDS. Quantitative sensory testing in cEDS
patients revealed mechanical pain hypersensitivity. Likewise, Col5a1+/- mice manifest widespread mechanical
allodynia, accompanied by abnormal skin innervation by nociceptors. Fibroblasts are the principal source of
abnormal type V collagen, and cEDS fibroblasts show transcriptome-wide changes, including genes related to
cell proliferation, migration, wound healing, and axonal guidance. While it has been recognized that fibroblasts
may contribute to peripheral sensitization of nociceptors through secretion of sensitizing molecules, in depth
studies into how fibroblasts communicate with the nociceptive system in peripheral tissues to initiate and/or
potentiate pain are surprisingly scant. Here, we will address this critical knowledge gap; we propose that cEDS
provides an excellent model for investigating how fibroblast-nociceptor interactions drive pain in cEDS and other
pain syndromes. We hypothesize that fibroblast-neuron interactions may cause hyperexcitability and/or
abnormal growth of nociceptors in the skin, two of the defining features of cEDS. We are in an unparalleled
position to examine this idea, owing to the unique, complementary resources and state-of-the-art techniques
present in our groups. In Aim 1, we will determine the innervation and cellular transcriptome in skin tissues of
cEDS vs control patients through immunohistochemistry and Visium. To do this, we will leverage the unique
cohort of molecularly and phenotypically characterized cEDS patients available through the Center for Medical
Genetics in Ghent, Belgium. In Aim 2, we will use a neuron-fibroblast microfluidic co-culture system to assess
the effect of Col5a1 mutant fibroblasts on neuronal excitability and neuronal growth/sprouting. In Subaim 2.1,
we will use murine cells to examine the effects of fibroblasts harboring a type V collagen defect on DRG neurons
in co-cultures. In Subaim 2.2, findings will be validated in human microfluidic co-cultures, using human iPSC-
derived sensory neurons with fibroblasts derived from cEDS patients or controls. We anticipate that the findings
generated from the proposed experiments will advance our knowledge of mechanisms underlying pain in cEDS,
and will generate important new information into mechanisms of more prevalent painful conditions where neuron-
fibroblast interactions play a role in the production of abnormal skin innervation and pain.

Public health relevance
Classic Ehlers Danlos Syndrome (cEDS) is characterized by skin hyperextensibility and fragility, abnormal wound healing, and joint hypermobility, accompanied by chronic widespread pain, refractory to analgesics. The proposed experiments focus on skin and interactions between dermal fibroblasts and neurons in molecularly elucidated cEDS patients. This is an entirely new direction in the field that will advance our knowledge of mechanisms underlying pain in cEDS, and generate important new information into mechanisms of more prevalent painful conditions where neuron-fibroblast interactions play a role in the production of abnormal skin innervation and pain.